Using real-time data capture to examine implicit attitudes as mediators of physical activity adherence in interventions

PROJECT SUMMARY
Approximately 42% of new cancer cases in the U.S. are viewed as potentially avoidable, including 15% caused
by excess body weight and physical inactivity. However, most U.S. adults are physically inactive. Physical activity
intervention research has focused primarily on modifying cognitions about what a rationally-thinking person
“should” do to improve their health, resulting in modest effects on long-term behavior change. A factor that has
been largely overlooked in intervention research is that while engaging in physical activity may be pleasant for
some, it can be an extremely unpleasant experience for others. How someone feels during behavior can trigger
associative processes including implicit attitudes (e.g., favorable/unfavorable) towards the target behavior that
operate quickly and involuntarily outside of cognitive control. A recent meta-analysis showed a significant positive
association between positive implicit attitudes towards physical activity and physical activity engagement. Our
data show implicit attitudes towards physical activity differ from day to day and across situations. A variety of
experimental strategies such as guided imagery and visualization have shown promise in changing implicit
attitudes towards physical activity. However, rarely have these intervention strategies been delivered in real-
world settings on a regular basis to address variations in implicit attitudes. We will examine whether implicit
attitudes towards physical activity can be experimentally manipulated by “affect-based” intervention strategies
delivered daily through interactive mobile technology and mediate intervention effects on physical activity
behavior. The proposed study will add innovative real-time measures of implicit attitudes during daily life among
adults (18+ years) at elevated cancer risk due to inactivity and overweight/obesity participating in an ongoing
trial (N=120). An “affect” condition provides daily goals related to enjoyment and feeling good during physical
activity. In contrast, an “intensity” comparison condition provides daily heart rate goals. Two daily enhancements
to the affect-based condition are evaluated: (1) tailored activity type and context recommendations to satisfy
personally important psychological needs (TYPE/CONTEXT) and (2) savoring practices to increase the saliency
of positive emotions during physical activity (SAVOR). On each day that they plan to engage in physical activity,
implicit attitudes will be assessed by a morning mobile Implicit Associations Test (IAT) on their smartphone
capturing reaction times to categorize physical activity and sedentary words as good or bad. Physical activity
outcomes are measured using accelerometry. Specific aims are (1) determine whether implicit attitudes mediate
effects of treatments on physical activity and (2) explore cross-situation moderating effects such as situational
constraints (e.g., incidental stress, pain, fatigue). This study will elucidate how, why, and when intervention
strategies can influence implicit attitudes and lead to successful physical activity change. Insights about effects
on the mediators can be back-translated into refinements in the treatment strategies themselves, leading to more
effective and sustainable interventions.

Public health relevance
PROJECT NARRATIVE Long-term maintenance of regular physical activity significantly lowers risks of cancer. Emotional responses during physical activity can trigger unconscious implicit attitudes towards the behavior (e.g., favorable/ unfavorable) that contribute to the likelihood of future behavior engagement. This study will examine whether implicit attitudes towards physical activity can be experimentally manipulated by daily “emotion-based” intervention strategies and whether changes in implicit attitudes lead to changes in physical activity behavior among adults at elevated risk of cancer due to inactivity and overweight/obesity.